ENICTO Consortium Coordinating Center

PROJECT SUMMARY ABSTRACT
The goal of the Exercise and Nutrition Interventions to Improve Cancer Treatment-related Outcomes (ENICTO)
Consortium is to support and enhance exercise and/or medical nutrition intervention research designed to
evaluate interventions that may improve cancer treatment-related outcomes among patients being treated with
curative of life-extending intent. The aims of the ENICTO Coordinating Center are to facilitate the work of the
ENICTO consortium by: 1) supporting the scientific goals of the ENICTO consortium through collection,
harmonization and analysis of common data across Consortium sites, 2) facilitating communication within the
Consortium and between the Consortium with external audiences, and 3) coordinating administrative functions
of the ENICTO consortium. Under the direction of the ENICTO Steering Committee, the ENICTO Coordinating
Center will work with Consortium investigators to identify common data elements and procedures across
Consortium sites, harmonize cohort variables, and identify opportunities for novel data collection to enrich the
ENICTO data resources. The Coordinating Center will organize training sessions for Consortium site staff to
ensure the quality, consistency, and completeness of the data across sites, develop and implement a data
management platform for data collection and reporting from the Consortium sites, and train and support
Consortium sites on platform use. The Coordinating Center will lead analyses for cross-consortium pilot
projects examining common research questions, and make the harmonized ENICTO data available to qualified
researchers based on Consortium policies and data sharing agreements. The Coordinating Center will plan
and coordinate the ENICTO Consortium Annual Meeting and meetings of the Steering Committee, establish
email listservs, develop and maintain a website for the ENICTO Consortium, plan and facilitate communication
among the scientific working groups, support the distribution of research materials such as study protocols and
education materials, and disseminate research findings to the scientific and cancer communities.
Administrative functions of the Coordinating Center will include development and implementation of ENICTO
operating policies and procedures pertaining to data sharing, publications and presentation, external
collaborations and ancillary studies under the guidance of the ENICTO Steering Committee, and an evaluation
system to track U01 site performance and project progress. The Coordinating Center will prepare meeting
agendas, compile meeting materials, record meeting minutes and action items, and provide general
administrative support and oversight.

Public health relevance
PROJECT NARRATIVE The ENICTO Consortium will conduct studies to evaluate the role of exercise and nutrition interventions in improving cancer treatment outcomes. The ENICTO Coordinating Center will enhance and support this research by: leading the development, collection, and analyses of common data across studies; facilitating communication within the Consortium and between the Consortium with external audiences; and providing administrative support for the Consortium.